SBIR PHASE I- TOPIC 410 - CANCER CLINICAL TRIALS RECRUITMENT AND RETENTION TOOLS FOR PARTICIPANT ENGAGEMENT.

This research project seeks to create targeted content and software, OncoEngage, to increase recruitment of oncology patients in clinical trials. The overall goal is to aid clinical research coordinators and others to engage prospective participants to join trials. The Phase I is focused on creating targeted content to engage and recruit participants into clinical trials and adapting customer relationship management software to enable research staff to efficiently and effectively perform engagement activities to recruit prospective participants.